Investigating Mic60 as a Novel Gene Therapy Target for Parkinson's Disease

ABSTRACT
At present, there are no treatments that hinder or halt the inexorable progression of Parkinson disease (PD), and
there is a critical need to identify treatments that can alter the course of the disease. The use of gene-transfer
therapy for neurodegeneration is a burgeoning field of research that has potential for directly addressing
progressive neuron loss at the cellular level. The key is to identify genetic therapies that will restore cellular
health and function, thereby altering the disease course. While the specific etiology of PD remains elusive,
evidence suggests that early dysfunction of mitochondrial respiration and homeostasis play a major role in PD
pathogenesis. The research focus of this proposal is to evaluate the potential of the essential mitochondrial
structural protein Mic60, also known as mitofilin, as an avenue to develop novel, translatable neuroprotective
strategies for PD.
Mic60 is a crucial component of a larger mitochondrial protein complex vital for maintaining mitochondrial
architecture and function, and loss of Mic60 can detrimentally affect mitochondrial homeostasis. Mic60 function
is regulated by interactions with proteins associated with PD, mitochondrial PINK1 and Parkin, which police
mitochondrial health and turnover. We previously found that cellular levels of Mic60 protein are decreased in the
dopamine toxicity model of PD. We also have evidence that Mic60 abundance is lower in PD patient brain.
Further, we found that Mic60 overexpression protects against PD-relevant toxicants, including the mitochondrial
poison rotenone. We hypothesize that the observed protective effects of Mic60 overexpression occur via
stabilization of mitochondrial function.
We propose to investigate the potential of Mic60 as a gene therapy candidate for PD via the following aims: In
Aim 1, we will determine the ideal dose and long-term safety of viral-mediated Mic60 overexpression in vivo for
delivery to the substantia nigra. In Aim 2, we will test the neuroprotective effect of Mic60 overexpression in vivo
in toxicity and genetic models of PD, to evaluate the potential of Mic60 as a targeted neuroprotective gene
therapy for PD. Our ultimate goal is to build on our in vitro data and evaluate Mic60 for development of a novel,
neuroprotective PD treatment. As mitochondrial dysfunction is a key contributor to PD and other
neurodegenerative diseases, targeting mitochondrial integrity via Mic60 to improve neuronal health may
yield a therapy for both genetic and sporadic forms of PD, and possibly other neurological disorders.

Public health relevance
PROJECT NARRATIVE Current treatments for Parkinson disease only address symptoms, and there are no therapies for Parkinson patients that impede neuron loss. We have evidence that overexpression of the crucial mitochondrial protein Mic60 protects dopaminergic cells against Parkinson-relevant stress. To test the potential of this protein having a role in translatable treatments, we will evaluate Mic60 for development of a novel, neuroprotective gene therapy for Parkinson disease.